Core 2: BioSecurity

Core 2: Biosecurity Core
Abstract
The Biosecurity Core is responsible for the protection of the NEIDL in support of a safe and secure research
environment. It does so by preventing unauthorized access to the perimeter, the facility, the BSL-4 laboratory
and storage locations in order to protect the select agent program from theft, loss and release and by serving
as the initial responder to incidents and events. The Biosecurity Core relies on an ongoing program of threat
and risk assessment and training, management of access control systems, and coordination with other cores
or departments in the management of the Personnel Suitability and Reliability Policy (PSRP). The Core is
integrated with campus-wide services and provides protective services to the NEIDL 24 hours/day, 7
days/week. The core is led by the Executive Director of Public Safety/Chief of Police and the Medical Campus
Public Safety Director and includes a Personnel Suitability Specialist, Systems integrators, Public Safety
Officers and Shift Supervisors. The Biosecurity Core interacts on a continuous basis with the Environmental
Health and Biosafety Regulations and Requirements Core (EHBRR), Facilities and Maintenance Core (FMO),
NEIDL leadership and NEIDL laboratory managers to review SOPs, staffing, security issues and incidents and
work collaboratively to ensure coordination between institutional and NEIDL programs. The Personnel
Suitability Specialist is responsible for the initial steps in the PSRP and the follow through as elements of the
process by EHRBB and Human Resources are completed. The Core then confirms that all requirements have
been met before assigning access in accordance with that policy. Clearances are initiated and checked initially
and then annually thereafter. Access is granted, adjusted or revoked annually or as needed. The Core is
represented on the Personnel Suitability Review Team and involved in issues that require adjustment of
access permissions. Systems Integrators manage a variety or security systems that allow access and do so in
coordination with FMO and NEIDL IT staff. NEIDL Public Safety Officers are sworn Special State Police
Officers licensed by the Massachusetts Department of Public Safety. They are trained and equipped with a
firearm and other protective tools. Officer training is not limited to the police academy and includes emergency
first responder, biological safety, and other NEIDL specific training. The Core not only participated in the
training programs but leads and instructs on trainings related to insider threat and CPR training programs. The
Biosecurity Core participates in exercises, provides subject matter expertise in their design when needed,
provides training to external first responders and meets with the Boston Biosafety Working Group (local
emergency medical, fire, police, public health) when necessary. The Core is involved in the transportation of
highly hazardous materials and serves as primary contact to external law enforcement agencies.